Implementing Vaccine and Treatment Evaluation Unit (VTEU) Clinical Site

DMID 24-0003 PROMISE
“A prospective, quasi-interventional Phase 4 study of the safety and serology of maternal RSVpreF
(ABRYSVO) vs. infant nirsevimab (BEYFORTUS) vs. administration of both products in infants during
the first year of life”.
Summary/Abstract
RSV is the leading cause of lower respiratory tract infections in infants and young children. It is also
a leading cause of mortality in children <5 years of age worldwide. Until recently, no FDA-approved
vaccines were available to prevent RSV infection in infants. Only the monoclonal antibody
palivizumab was available to high-risk infants, but administration was limited to those with extreme
prematurity, chronic lung disease, or hemodynamically significant congenital heart disease.
However, in 2023, the FDA approved two products designed to prevent RSV lower respiratory tract
disease in all infants: an active RSV vaccine based on the pre-fusion F protein (RSVpreF, ABRYSVO,
Pfizer) administered during pregnancy and a passive, long-acting monoclonal antibody (nirsevimab,
BEYFORTUS, AstraZeneca) administered to infants at birth or at the start of the first RSV season.
Both products have been evaluated in phase 3 pivotal clinical trials and have been found to have
high efficacy in the prevention of RSV lower respiratory tract disease in infants. However, the
magnitude and durability of antibody responses following administration of the products have not
been directly compared. Furthermore, the added benefit of administering both products to an
infant has not been characterized. While cost-effectiveness analyses have demonstrated that
administration of both products is not cost-effective or indicated for most infants, it is likely that
some infants may receive both products inadvertently, and still others may benefit from both. These
include infants born to women who may not have mounted adequate antibody response to
vaccination (e.g. due to immunocompromise, prematurity, or insufficient time from vaccination to
delivery) or who may have had impaired antibody transfer across the placenta (e.g. due to placental
pathology). It also includes high-risk infants (e.g. with prematurity or chronic lung disease) who may
benefit from an interval dose of nirsevimab to protect in the setting of waning antibodies and off-
season RSV circulation. Thus, understanding the safety and serology of administration of both
products vs. either product alone is of clinical and public health importance. These knowledge gaps
underly the objectives for this study.
DMID 23-0006 ETEC
“A Phase 2b, Double-Blind, Placebo Controlled Trial to Evaluate the Efficacy of Intramuscularly
Administered CssBA+dmLT against Moderate-severe Diarrhea in a Controlled Human Infection
Model with Enterotoxigenic Escherichia coli (ETEC) Strain B7A in Healthy Adults”
Summary/Abstract
Enterotoxigenic Escherichia coli (ETEC) is an important cause of bacterial diarrhea resulting in
significant morbidity and mortality, especially in children under 5 years of age living in low-and
middle-income countries (LMIC) and travelers visiting LMICs. Annually, ETEC is estimated to cause
approximately 220 million diarrheal episodes globally, with about 75 million of those episodes
occurring in children <5 years of age, resulting in more than 40,000 deaths. Asymptomatic ETEC
infection, or repeated episodes of diarrhea with various pathogens including ETEC, have been
correlated with malnutrition, stunted growth, and impaired cognitive development. The
pathogenicity of ETEC is associated with the production of colonization factors (CFs) heat-labile
(LT) and heat-stable (ST) toxins. Coli surface antigen 6 (CS6) is a widely expressed ETEC CF that
mediates bacterial attachment to the small intestinal epithelium. Blocking CF adherence is thus
thought to be an effective means to prevent infection. This has resulted in a CF/enterotoxin-targeted
approach as the primary strategy for many of the current ETEC vaccines in development. In an
open-label Phase I clinical trial, the current prototype CS6-based subunit vaccine (CssBA) was safe
and well-tolerated with vaccine-related adverse events (AEs) consisting predominately of short-
lived vaccine site reactions. Based on the safety and robust immunogenicity of CssBA, we now will
evaluate the efficacy of this vaccine using a controlled human infection model (CHIM).

Public health relevance
DMID 24-0003 PROMISE “A prospective, quasi-interventional Phase 4 study of the safety and serology of maternal RSVpreF (ABRYSVO) vs. infant nirsevimab (BEYFORTUS) vs. administration of both products in infants during the first year of life”. PROJECT NARRATIVE Although maternal vaccination with RSVpreF and passive immunization of infants with nirsevimab have both been approved for the prevention of RSV lower respiratory tract infection in all infants, the two products have not been directly compared in a single study. Furthermore, the sequential administration of both products may be indicated for some infants, the safety and serology of this approach has not been evaluated. This project will provide an understanding of the safety and serology of administration of both products vs. either product alone which can guide clinical decision making for pregnant women and their infants. DMID 23-0006 ETEC “A Phase 2b, Double-Blind, Placebo Controlled Trial to Evaluate the Efficacy of Intramuscularly Administered CssBA+dmLT against Moderate-severe Diarrhea in a Controlled Human Infection Model with Enterotoxigenic Escherichia coli (ETEC) Strain B7A in Healthy Adults” PROJECT NARRATIVE The study is designed to evaluate the safety, efficacy, and immunogenicity of the intramuscular administration of a CS6 based vaccine against ETEC (CssBA) co-administered with double mutant labile toxin (dmLT) in preventing MSD following challenge with ETEC strain B7A in healthy adults. ETEC is an important cause of bacterial diarrheal illness among children under 5 years of age in low-and middle-income countries and the leading cause of travelers’ diarrhea among people traveling to ETEC endemic regions. As ETEC infections follow ingestion of contaminated food or water, access to clean water and increased hygiene could significantly decrease the burden of illness caused by ETEC. While these long-term goals are being addressed, other means to protect against ETEC, including vaccines are needed.